Effects of age and hearing loss on auditory temporal processing: Perceptual and electrophysiological measures

Human communication crucially depends on the ability to maintain good speech intelligibility in dynamically
varying acoustic backgrounds. This ability declines with age and age-related hearing loss. Understanding the
mechanisms underlying this decline is key to finding successful interventions and potential treatments for this
widespread problem of high public-health relevance. Recently, magneto- and electroencephalographic
(M/EEG) measures have been increasingly used to investigate changes in subcortical and cortical neural
processing due to age and hearing loss. Advances in measurement and data analysis methods enable
characterization of neural tracking of acoustic, and higher-level (linguistic and semantic) speech features from
M/EEG recordings obtained while study participants listen to continuous speech. These techniques provide a
unique window into neural tracking of the target speech and to-be-ignored competing background. However,
the interpretation of these measures is hampered by poor control for differences in peripheral (cochlear)
auditory function, lack of direct experimental validation for the role of specific underlying mechanisms, and
often small study samples. Non-speech stimuli have been used to gain a better understanding of specific
mechanisms contributing to the age- and hearing-loss-related decline in speech perception but experimental
evidence that individual or group differences in neurophysiological responses to these stimuli are reflected in
perception is often lacking. The goal of this proposal is to provide the missing link between measures of
cortical tracking of temporal envelope fluctuations in non-speech and speech stimuli and performance in
perceptual tasks, using comparable stimuli. The studies will use young normal-hearing listeners, older normal-
hearing listeners, and older hearing-impaired listeners. In Aim 1, we will investigate effects of age and hearing
loss on perceptual measures of modulation-rate selectivity and discrimination using non-speech well-controlled
stimuli with envelope modulation rates relevant for speech perception. In Aim 2, we will measure cortical
responses to the non-speech stimuli used in these perceptual tasks to establish the sensitivity of EEG-based
measures to changes in perception resulting from comparable experimental manipulations. In Aim 3, we will
estimate cortical responses to speech envelope for natural (continuous) speech stimuli to investigate
contributions from loss of cochlear nonlinearity, changes to modulation-rate selectivity and discriminability, and
changes to cognitive function to neural processing and perception of masked speech. The outcomes from this
project will provide the experimental basis for interpreting noninvasive neural (cortical) measures of temporal-
envelope processing, thus advancing our understanding of mechanisms contributing to deficits in speech-in-
noise perception experienced by older normal-hearing and hearing-impaired adults. The results from the
project will have an impact on the development of potential future interventions and treatments for
communication problems that are widespread among the growing population of older individuals.

Public health relevance
Neural tracking of natural speech provides an exciting new window into human communication abilities. However, many basic questions about what the neural tracking reflects, and how it could be utilized in the diagnosis and treatment of hearing disorders, remain unanswered. This project will characterize the cochlear, neural, and cognitive contributions to age- and hearing-loss-related changes in the perception and neural responses to speech.